Genome-wide CRISPR screening identifies critical regulators controlling ccRCC lung metastasis

Clear cell renal cell carcinoma (ccRCC), which accounts for approximately 85% of all renal cancers, is resistant
to a variety of cancer therapies and is highly lethal. Metastasis poses a significant challenge in the treatment of
kidney cancer, with lung metastasis accounting for approximately 40-50% of all kidney cancer metastases. While
the 5-year average survival rate for kidney cancer without metastasis is approximately 90%, the survival rate for
distant metastasis (such as lung, bone and brain) is only 10-15%, emphasizing the urgent need to understand
the biology underlying kidney cancer lung metastasis. Here we perform a genome-wide Clustered Regularly
Interspaced Short Palindromic Repeats (CRISPR) screen and identify that Hepatic leukemia factor (HLF)
controls lung metastasis in ccRCC. Most of the reports about HLF focused on leukemia studies and its function
in solid cancer has never been characterized. This proposal, for the first time, will characterize the role of HLF
in ccRCC lung metastasis and examine its underlying molecular mechanism. In Specific Aim 1, we will
characterize the functional significance of HLF on kidney cancer lung metastasis by using gain-of-fuction and
loss-of-fucntion studies in ccRCC orthotopic xenograft tumors, patient derived xenograft (PDX) models, immune-
competent mouse models and humanized mouse models. In Specific Aim 2, we will delineate the molecular
mechanism by which HLF loss promotes kidney cancer lung metastasis by integrated ChIP-Seq and RNA-Seq
analysis. In particular, we will delineate the molecular mechanism of HLF-LPXN on regulating ccRCC migration
at the single cell level. Successful completion of these aims will provide mechanistic insight into signaling
pathways controlling lung metastasis in ccRCC and set the foundation for therapeutic intervention targeting the
HLF signaling axis in ccRCC.

Public health relevance
It is imperative to elucidate the molecular mechanism for ccRCC lung metastasis, which accounts for majority of poor patient outcome. Here we performed a genome-wide CRISPR-Cas9 screen and identified HLF as the critical gene controlling ccRCC lung metastasis. This study, if successful, will set the foundation for therapeutic intervention targeting lung metastasis in ccRCC.